Task C11:Non-Human Primate Model for Filovirus Vaccine Efficacy and Immunogenicity Testing

This contract provides for the development and standardization of non-human primate models for infectious diseases, and may include efficacy testing of candidate products, including GLP studies to support licensure.